PHYSIOLOGICAL &BEHAVIORAL INFLUENCES OF SEROTONIN

The regulation of the naturally occurring neurotransmitter serotonin in the central nervous system (CNS) can be assessed indirectly by measuring physiological and behavioral responses following the administration of a serotonergic medication. The purpose of this pilot study is to assess neuroendocrine responses and eating behavior following single-dose administration of the recently approved serotonergic antidepressant medication citalopram (Celexa) (TM).